Vet-LIRN: Improving infrastructure and response capabilities at the Connecticut Veterinary Medical Diagnostic Laboratory

Project Summary
The objective of this cooperative agreement between the Food and Drug Administration
(FDA) Veterinary Laboratory Investigation and Response Network (Vet-LIRN) and the
Connecticut Veterinary Medical Diagnostic Laboratory (CVMDL), University of
Connecticut, is to provide the network with increased sample testing and data analysis
capabilities.
By obtaining support from FDA via the 5-years infrastructure grant, CVMDL will be able
to support interventions by the network in events that compromise the health or well-
being of animals.
CVMDL will be able to provide testing;
 Including routine microbiological analysis of samples submitted by Vet-LIRN to
the laboratory, including feed samples, environmental samples, and clinical
samples derived from different animal species.
 CVMDL will conduct testing if samples are collected during outbreak
investigations or surveys conducted by FDA or through the network by State and
Federal Government agencies.
 CVMDL will conduct necropsies of animals submitted by Vet-LIRN for testing or
for case investigation purposes.
 This cooperative agreement will support proficiency testing and training activities
as directed by the Vet-LIRN.
 Funding requested by CVMDL to FDA Vet-LIRN will be used to procure
necessary supplies, maintain equipment, and partially support laboratory
personnel salaries.
Our successful current and past participation in the Vet-LIRN demonstrates our keen
interest in investigating emerging threats to animal health. CVMDL as a nationally
accredited laboratory has qualified personnel and a comprehensive quality assurance
program. The expertise and knowledge available at CVMDL and the University of
Connecticut warrant the feasibility and execution of this agreement.

Public health relevance
Project Narrative This FDA Vet-LIRN Cooperative Agreement Program will strengthen the overall food safety system in the USA. The agreement will increase CVMDL's capacity to detect animal health threats, including feed-born-related illnesses. These threats can affect animals raised for human consumption or companion animals that may have a detrimental impact on public health.